Personalized Neuromodulation Targeting Dysregulated Motivational Responses Underlying Social Avoidance Behavior

PROJECT SUMMARY/ABSTRACT
Social avoidance behavior (SAB) plays a critical role in the development, maintenance, and chronicity of
internalizing disorders such as Major Depressive Disorder (MDD) and Social Anxiety Disorder (SAD).
Although current treatments reduce internalizing symptoms, these treatments fail to reduce SAB, which
contributes to symptom re-occurrence. Thus, there is an urgent need for innovative approaches that effectively
reduce SAB in patients with internalizing disorders. Preliminary data suggest that SAB is associated with
dysregulated approach-avoidance (AA) motivational responses to co-occurring social reward and social threat
(i.e., social reward-threat conflict). Dysregulated AA motivational responses are associated with disrupted
task-related connectivity between the pregenual anterior cingulate (pgACC) and dorsolateral prefrontal cortex
(dlPFC) as well as weakened intrinsic connectivity between the larger Salience Network (SN) and Default Mode
Network (DMN) systems. Thus, the immediate goal of this proposal is use transcranial magnetic stimulation
(TMS) to causally modulate patient-specific pgACC-dlPFC dysfunction during AA motivational responses and
intrinsic SN-DMN dysfunction in patients with MDD (n = 20) or SAD (n = 20). The long-term goal of this
proposal is to develop neuroscience-guided interventions that reduce SAB by remediating patient-specific
neural circuit dysfunction. To meet this goal, the candidate proposes training objectives supported by a
mentorship team with expertise in 1) basic and translational applications of TMS (Dr. Michael Esterman and
Dr. Joan Camprodon), 2) neural connectomics and individualized brain mapping (Dr. Jorge Sepulcre and Dr.
Mark Halko), and 3) conducting and evaluating clinical trials for experimental therapeutics (Dr. Charles Taylor
and Dr. Thomas Travison). The central hypothesis of the proposed research is that TMS protocols over patient-
specific right dlPFC targets will rescue (continuous theta-burst; cTBS) or not modulate (sham) dysregulated AA
motivational responses and task-related pgACC-dlPFC connectivity to social reward-threat conflict as well as
intrinsic SN-DMN connectivity. Thus, the current study proposes a cross-over clinical trial with specific aims to
characterize transdiagnostic effects of personalized cTBS on these processes. This approach is innovative
because it uses personalized neuromodulation guided by both patient-specific neural network topography and
functionality underlying dysregulated motivational processes. The proposed study is significant because it has
the potential to advance our understanding of the pathophysiology of SAB and provide crucial data towards
developing a precision-medicine approach that utilizes personalized neuromodulation to effectively target and
reduce SAB. In sum, the candidate is fully committed to using the proposed project and training plan to build
an independent program of neuroimaging and neuromodulation research to delineate and remediate neural
circuitry underlying social dysfunction across internalizing disorders.

Public health relevance
PROJECT NARRATIVE Social avoidance behavior (SAB) plays a key role in the development and maintenance of internalizing disorders such as Major Depressive Disorder and Social Anxiety Disorder, but is largely resistant to current treatments. The proposed research seeks to address this issue by using precision neuromodulation to regulate motivational and neural processes that contribute to SAB across internalizing disorders.